SWOG 94-20 CORRELATION OF THYMIDYLATE SYNTHASE IN 5 FU TREATED COLORECTAL CANCER

This is a randomized trial of two different methods of administering 5-FU plus leukovorin in the treatment of colon cancer. Samples of the tumor will be assayed for thymidylate synthase (TS) message by RT-PCR, following which the patients will be randomized to receive intermittent high dose 5- FU infusion or continuous low dose infusion. Patients will continue to receive the same therapy until either toxicity or poor response occurs. Response will be correlated with apparent TS levels.